Targeting the Gut Mycobiome in Ulcerative Colitis

Project Summary/Abstract
This K23 Mentored Patient-Oriented Research Career Development Award proposal will provide experiential
training, cohesive mentorship, and a fantastic research environment facilitating Dr. Sushrut Jangi’s
development as an independent clinician scientist. His long-term career goal is to deliver personalized
microbiome-directed treatments to improve outcomes in patients with ulcerative colitis (UC). A disabling
disease, UC affects 1 million patients nationally, leading to gastrointestinal symptoms, recurrent relapses, and
reduced quality of life. Current management is limited to biologic therapies with an efficacy of only ~30-50%.
There is a dire need for more efficacious treatments, including those targeting the microbiome. Optimizing
these treatments has called for considering microbes beyond bacteria, including fungi (the mycobiome).
Recent evidence strongly supports that the fungal microbe Candida albicans is implicated in perpetuating
colonic inflammation and in UC relapse. However, assessing and directly targeting C. albicans in UC remains
unexplored. The current proposal will address this knowledge gap. The overall objectives are to 1) evaluate the
mycobiome as a predictor of biologic-treatment failure 2) identify competitive interactions between the
bacteriome and C. albicans in vitro 3) test the feasibility and preliminary efficacy of adjunctive fluconazole to
alter the mycobiome and improve UC outcomes. To achieve these aims, 40 active UC patients initiating
biologic-therapies will be prospectively recruited. Longitudinal fecal samples will be collected to determine if
persistent elevations in C. albicans are associated with biologic-treatment failure. Second, the growth of patient
stool-derived C. albicans strains will be tested in the presence of bacterial strains, to identify if specific bacteria
or their metabolites may regulate C. albicans growth in vitro. Finally, in a pilot randomized controlled trial, 36
patients with active UC will receive 14 days of 200 mg of fluconazole or placebo, in addition to standard
immunosuppression. Primary outcomes of feasibility of this intervention, and secondary outcomes of microbial
changes and clinical outcomes will be assessed. This proposal’s outcomes are expected to determine if C.
albicans may predict biologic-treatment failure, to identify bacteria that antagonize C. albicans, and to test if
targeting the mycobiome may reduce C. albicans and improve UC outcomes. Dr. Jangi is a gastroenterologist
with a background in clinical research. However, he requires advanced training in mixed-effect models to
assess the dynamic microbiome alongside patient covariates, assessment of microbial functions and
communities through shotgun metagenomics and co-abundance measures, translational research, and in
clinical trial design and execution. He has assembled a strong mentorship team led by Dr. Dominique Michaud,
spanning national experts in microbiology, inflammatory bowel disease, the microbiome, and clinical trial
development. This approach, combined with the outstanding resources available at Tufts Medical Center and
Tufts University, will ensure Dr. Jangi’s success in his transition to an independent investigator.

Public health relevance
Project Narrative Ulcerative colitis, a chronic debilitating inflammatory bowel disease, is currently managed with biologic treatments achieving an efficacy of only 30-50%, underscoring an urgent need for new therapeutic strategies. Despite the known association of the gut fungal mycobiome, particularly Candida albicans, with colonic inflammation and disease relapse, microbiome-directed strategies have not incorporated the mycobiome as a treatment target. This study will examine if the mycobiome can be utilized to predict biologic-treatment failure, if specific bacteria may inhibit C. albicans growth, and if directly modulating the mycobiome may lead to enhanced clinical outcomes for patients with ulcerative colitis.